Dissecting the Role of Long Range Prefrontal Circuits in Early-life Stress Induced Susceptibility

Contact PD/PI: Atsak, Piray
Project Summary
My career goal is to become an expert on the circuit level mechanisms of neural
transmission underlying developmental stress and individual differences in stress
response and sensitivity. I plan to lead a research lab studying the neurophysiological
mechanisms of early-life stress (ELS) and the emergence of individual differences in
adult stress response. ELS creates long-term risk to depression and anxiety disorders,
particularly after facing stressful events during adulthood. However, little is known about
how ELS produces sustained changes at the neural circuitry level that increase
sensitivity to stress later in life. This kind of detailed circuit dissection cannot be
performed in humans, thus by using a recently established two-hit model of early-life
and adult stress in mice in which stress during a specific postnatal window increases the
likelihood of adulthood stress to induce depressive-like behaviors. With this K01 grant
and under the mentorship of Dr. Rene Hen at RFMH and Columbia University, I will test
the role of long-range prefrontal circuits in the ELS-induced susceptibility to adult stress. I
will combine an established two-hit mouse model of stress with advanced methods such
as multi-site electrophysiological recordings and intersectional approaches for pathway
specific chemogenetic manipulations. These studies represent a number of firsts in the
developmental/systems neuroscience field: 1) the first to test the role of some of the long-
range prefrontal cortex associated circuits (prefrontal-accumbens, amygdala, ventral
hippocampus) activity and communication in stress susceptibility; 2) the first to dissect
neural circuit activity and communication underlying the ELS-induced changes in adult
stress response; 3) the first to investigate the impact of ELS in stress-susceptibility and
underlying neural circuits in females; 4) the first to combine developmental stress with
simultaneous multi-site recordings and intersectional approaches for pathway specific
manipulations. These studies represent a significant career change and research
redirection for me. This K01 award will afford me the mentorship and additional training
that will prepare me to achieve my career goals and establish an independent research
program geared towards investigating the neural circuits of which ELS leads to lifelong
susceptibility to depression and psychiatric disorders.
Project Summary/Abstract